ASSESSMENT OF THE SIZE OF THE LEAK INDUCED IN RETINAL VESSELS USING PITC-DEXTRANS

Uveitis was induced in two monkeys by immunization with IRBP and serial fluorescein angiograms preformed using different sized dextrans linked to fluorescein. The aim of these studies is to provide data on the retinal vessels and toxicology data to enable these agents to be used in humans. We have demonstrated that the larger molecular weight dextrans are less premeable than sodium fluorescein in the inflamed retina.